Diversity Supplement for a STEM diversity trainee in the lab

Project Summary
To determine the anatomical basis of complex neural behavior, it is critical to have the ability to
trace more than one circuit simultaneously in the same animal. That’s because complex animal
behaviors or neural computation should be understood through the interaction of more than one
circuit – cooperative, antagonistic, or else. In addition, it is necessary to rapidly capture the
connectivity information in the dynamically changing brains during development and learning.
Engineered G-deleted rabies is a current state-of-art method to retrogradely trace the presynaptic
input neurons of a defined cell type. However, it remains unfeasible to trace more than one neural
circuit simultaneously. In addition, the current approach using AAV helpers and rabies requires
several weeks for tracing. In this proposed research, we will overcome these disadvantages by
developing two novel trans-synaptic viral tracer systems: SWORD: Sendai with Orthogonal
Rabies Duplex Tracing (Aim 1) and a rapid TRIO/cTRIO: cell-type specific tracing the relationship
between input and output (Aim 2). This research is significant because these new methods will
allow more comprehensive analysis of neural connectivity in more than one circuit and in more
diverse context such as the developing brain where distinct synaptic networks emerge and neural
plasticity such as learning across many model species. The proposed research is innovative,
because we are developing and validating technically innovative solutions, SWORD and rapid
TRIO/cTRIO, to overcome the limitations of the current state-of-the art tracing method. These
viral-genetic tools will have a positive and broad impact on the neuroscience field as it will
enhance our understanding of neural circuit organization for the complex behaviors and help to
identify the circuit-specific therapeutic targets to cure brain disorders.

Public health relevance
Project Narrative Understanding the neural circuit organization at great precision is a prerequisite to understand the brain functions underlying complex animal behaviors. In this proposed research, we will develop and validate two novel trans-synaptic virus tracer systems to delineate the neural connectivity orthogonally and rapidly. Our proposal has high levels of public health relevance because utilizing our methods to study brain connectivity will enhance understanding of neural circuit organization in both normal and diseased brains, which aligns with NIH’s mission to identify the circuit-specific therapeutic targets to cure brain disorders.